Michigan Center for Translational Cancer Proteogenomics

Abstract
Pediatric cancers exhibit unique biological features, including significant germline predisposition
and aberrant developmental pathway activation, necessitating specialized research approaches.
This supplement proposes to expand the University of Michigan Proteogenomic Data Analysis
Center (PGDAC) to perform comprehensive proteogenomic analyses tailored for the Gabriella
Miller Kids First (Kids First) cohort and other pediatric datasets. We will create 'ProKids', an
integrated, harmonized pediatric proteogenomic resource (focusing initially on hematological
malignancies), enabling comparative analyses across diverse pediatric malignancies and against
adult cancers to identify unique molecular features and signaling alterations. Key objectives
include: 1) Utilizing 'ProKids' for multi-omic comparative analyses to discover novel therapeutic
targets, with a specific focus on identifying cell surface antigens for immunotherapies; 2)
Integrating proteogenomic data with germline sequencing to functionally interpret inherited
variants (including VUS) and understand their impact on pediatric cancer biology and outcomes;
and 3) Interrogating tumor proteomes, PTMs for aberrant developmental signatures to uncover
unique dependencies and vulnerabilities suitable for targeted therapies. This initiative will
leverage proteogenomics to unlock unprecedented insights into pediatric cancers, providing
critical resources and knowledge to advance treatments for childhood illnesses.

Public health relevance
Narrative Childhood cancers are distinct diseases with unique causes, and current treatments often lead to severe long-term side effects for young survivors. This project will analyze proteins and genes together in a large collection of pediatric hematological malignancy samples (including from the Kids First project and CCDI) to uncover the specific biological mechanisms driving these cancers. By identifying unique vulnerabilities, including disrupted developmental processes and specific markers on tumor cells, this research will pave the way for developing more effective and less toxic therapies, ultimately improving the health and quality of life for children with cancer.